Structural and Functional Characterization of the S. cerevisiae mRNA export platform

Project Abstract:
The nuclear pore complex (NPC) is an ancient molecular machine embedded in all eukaryotic nuclear
membranes that acts as a physical gatekeeper for macromolecules that enter or leave the nucleus. mRNA is
bound by RNA-binding proteins to form messenger ribonucleoprotein particles (mRNPs) that aid in transit across
the NPC so that they may exit into the cytoplasm to be translated into proteins. The NPC mediates mRNP export
along a pathway that is distinct from transport of proteinaceous or ribosomal cargoes that culminates at a highly
conserved cytoplasmic export location termed the mRNA export platform. At the mRNA export platform, mRNPs
are remodeled, undergoing conformational and compositional changes, to facilitate release of packaged mRNA
for translation into the cytoplasm. Mutations in or mis-regulation of proteins in the mRNA export pathway and
particularly at this critical export complex are implicated in developmental defects, cancer, and in particular, aging.
Previous studies that combined crosslinking mass-spectrometry and negative-stain electron microscopy with
integrative modeling strategies yielded a low-resolution map of the architecture of the complex, but a high-
resolution map of the entire mRNA export platform that yields molecular insights into the assembly of the complex
and identifies key points of regulation has eluded us. Additionally, recent work has provided substantial evidence
that the NPC has a functional role in post-transcriptional gene regulation, with preliminary data indicating that
dysfunction in the mRNA export platform leads to disruption in this regulatory role. The goal of this proposal is
to understand the molecular determinants of mRNA export platform assembly and elucidate the mechanisms by
which aging-associated mutations affect platform assembly and lead to aberrant gene regulation, therefore
manifesting in the onset of premature aging. Aim 1: To leverage single particle cryo-EM of the core Nup82
complex, as well as reconstitution biochemistry, crosslinking mass-spectrometry, and negative stain EM to
generate a high-resolution integrative model of the mRNA export platform, onto which aging-associated
mutations can be mapped to understand how these mutations disrupt platform assembly. Aim 2: To generate
yeast strains carrying these aging-associated mutations that can be functionally characterized to uncover the
mechanisms by which the mRNA export platform regulates gene expression and elucidate how these mutations
affect this critical function and give rise to aging phenotypes. This work would give us an unprecedented
understanding of post-transcriptional gene regulation at this critical mRNA export and remodeling site.
Furthermore, this study would reveal new structural and molecular insights into the highly documented but poorly
understood role of NPC dysfunction in the onset of aging and disease.

Public health relevance
Project Narrative: Macromolecule transport in and out of the nucleus occurs via the nuclear pore complex (NPC) and dysfunction at the highly conserved mRNA export platform of the NPC, a critical site of post-transcriptional gene regulation, has been heavily implicated in disease and aging. This proposal aims to integrate single particle cryo-EM and crosslinking mass spectrometry to generate a high-resolution model of the mRNA export platform, to which aging-associated mutations can be mapped and points of regulation identified. Concurrently, I will functionally characterize disruptive export platform mutations to understand the platform’s role in gene regulation and elucidate the mechanisms by which these mutations disrupt this regulatory function and manifest in aging phenotypes.